Phenotype Interactions in SCLC Development and Detection

PROJECT SUMMARY
Small Cell Lung Carcinoma (SCLC) is an aggressive neuroendocrine subtype of lung cancer. SCLC
patients have a very low 5-year survival, in part because SCLC tumors are often detected at a late stage when
the tumors have already metastasized and treatment outcomes are worse. Thus, early detection becomes
critical to achieve better treatment results. Emerging evidence supports the idea that, while SCLC tumors seem
homogeneous when examined under a microscope, these tumors contain a significant level of intra-tumoral
heterogeneity. Indeed, recent observations by our group and others have identified distinct cellular phenotypes
in SCLC, including in primary human tumors, in cell lines derived from human tumors, and in tumors from
genetically-engineered mouse models. Importantly, data from our group indicate that these cellular phenotypes
contribute to SCLC development. The specific goal of this proposal is to elucidate how different cellular
subpopulations within SCLC tumors drive early SCLC development, dynamics, and growth and to leverage this
mechanistic information to identify biomarkers for early detection and prevention of SCLC.
We have previously identified tumor-propagating cells (TPCs) in SCLC tumors and found that these cells
are neuroendocrine and strongly tumorigenic. We have also characterized cell populations derived from these
TPCs with distinct phenotypes, including non-neuroendocrine NOTCH+ and CD44+ subpopulations, that
promote the growth and survival of the neuroendocrine TPCs. Leveraging these findings as well as our unique
genetic mouse models that allow dissection of SCLC phenotype evolution, we will investigate how cell-cell
interactions of these distinct SCLC cell phenotypes contribute to tumor development and growth, in relationship
with the tumor microenvironment. We will also elucidate the role of secretory factors released by these SCLC
subpopulations in driving survival, growth, and phenotype composition of SCLC tumors. Finally, we will
perform analysis of cfDNA and proteins (including on exosomes) present in SCLC patient plasma for
identification of related markers of SCLC development and early detection. We will also follow up on intriguing
findings that germline mutations in NOTCH are present in a large fraction of SCLC patients, suggesting a
potential risk marker beyond smoking.
This interdisciplinary basic-translational project will elucidate fundamental mechanisms of SCLC
development and may lead to novel methods for early detection and/or prevention of SCLC.

Public health relevance
PROJECT NARRATIVE We will investigate how intrinsic cellular heterogeneity in SCLC tumors and distinct cell populations within the tumors communicate and promote tumor cell survival and growth. Combined with analysis of early stage SCLC patient samples to identify and test clinical markers of this intrinsic biology, the proposed approaches will elucidate cellular mechanisms of SCLC development and may help identify novel strategies for early detection of SCLC.